Effects of chronic intermittent hypoxia on cholinergic modulation at hypoglossal motoneurons

Project Summary/Abstract
Exposure to chronic intermittent hypoxia (CIH) is a common consequence of obstructive sleep apnea (OSA)
where patients experience repeated apneas and hypopneas throughout the night. Accumulating evidence
indicates that CIH can lead to structural and functional changes in the brainstem neurons that control breathing.
Normally, activity of the tongue, innervated by hypoglossal motoneurons, stiffens the airway to keep it open, but
this activity drops dramatically during sleep and contributes causally to OSA in susceptible individuals. During
sleep, reduced hypoglossal motoneuron activity likely results from activation of sleep-specific muscarinic (i.e.
activation of muscarinic acetylcholine receptors) modulation at hypoglossal motoneurons. The specific effects
of muscarinic modulation will depend on the muscarinic acetylcholine receptors present, where M1, M3, and M5
muscarinic receptors have canonically excitatory effects whereas the M2 muscarinic receptor subtype has a
canonically inhibitory effect, as well as the compliment of ion channels that are modulated by muscarinic
receptors. This project will explore the hypothesis that CIH leads to significant changes in cholinergic synaptic
inputs to, and cellular properties of, hypoglossal motoneurons resulting in an increased excitatory effect of
muscarinic modulation at hypoglossal motoneurons. This project uses powerful immunofluorescence methods
in combination with in vitro electrophysiology to evaluate neuroanatomical as well as functional changes in
cholinergic signaling at hypoglossal motoneurons in two specific aims. In Aim 1, the project will determine the
expression pattern of muscarinic acetylcholine receptor subtypes in neonatal and adult mice exposed to chronic
intermittent hypoxia compared to mice naïve to chronic intermittent hypoxia. This aim will also explore changes
in the cholinergic inputs to hypoglossal motoneurons in response to chronic intermittent hypoxia exposure. In
Aim 2, the project will use electrophysiology techniques to test in neonatal and adult mice the functional changes
of muscarinic modulation at hypoglossal motoneurons in response to chronic intermittent hypoxia exposure. This
aim will evaluate these effects both at the network level using the rhythmic slice preparation and also in individual
hypoglossal motoneurons using whole cell electrophysiology methods. These studies will contribute excellent
training opportunities for graduate and professional students, thus providing scientific training to the next
generation of clinicians. Furthermore, the expected outcomes will advance understanding of cellular and
synaptic cholinergic mechanisms that change in response to exposure to chronic intermittent hypoxia. This
fundamental information will be essential to develop strategies to explore in vivo the cholinergic mechanisms
that contribute to state-dependent reductions in airway tone and how those mechanisms change in response to
chronic intermittent hypoxia exposure. These data will contribute to the mission of the National Heart Lung, and
Blood Institute of improving the health and quality of Americans suffering from sleep disordered breathing.

Public health relevance
Project Narrative During sleep, patients who suffer from obstructive sleep apnea stop breathing many times a night because upper airway muscles including the tongue collapse and block the airway, which leads to cyclically low levels of oxygen. This project will test the hypothesis that the cyclical low levels of oxygen change the effects of acetylcholine (normally released during sleep) at the motoneurons that control the tongue. This proposal will advance understanding of this important mechanism that regulates airway tone during sleep to facilitate discovery of potential novel treatment options for obstructive sleep apnea.